Planning and Evaluation Core

PROJECT SUMMARY
The Planning and Evaluation Core (PEC) is responsible for monitoring the progress of Partnership components
and of the Pacific Island Partnership for Cancer Health Equity (PIPCHE) as a whole and providing guidance
and input to ensure success. The PEC also supports the continuous progress of PIPCHE by providing for the
development, review, and funding of new research projects, as well as evaluation of existing projects and
cores and PIPCHE overall.